PHARMACOKINETIC AND PHARMACODYNAMIC TRIALS FOR MEDICATION DEVELOPMENT IN SUD. TO1 PHASE 1 COCAINE DRUG INTERACTION SEPTEMBER 25, 2023 TO MARCH 24, 2025. N01DA-23-893

Pharmacokinetic and Pharmacodynamic Trials for Medication Development in SUD